Cerebellar connectivity and error-based learning in infants at risk for autism

Project Summary Autism Spectrum Disorder (ASD) is a heterogeneous disorder diagnosed on the basis of social impairment and restricted, repetitive behaviors 7. To combat these behavioral liabilities, effective interventions are needed. Early interventions appear particularly promising given evidence that engaging in therapies by 18-24 months improves outcomes for individuals with ASD 8–11. However, prospective research in infants at high risk for ASD has shown that the defining behavioral features of ASD are not present during the first year of life 12. Thus, very early intervention will rely on the identification of reliable presymptomatic biomarkers. In service of this objective, we propose to interrogate cerebellar functional connectivity and error-based learning (EBL) impairment as developmentally-linked neural and physiological presymptomatic biomarkers, respectively, of ASD. Converging evidence from multiple areas of research indicates a role for the cerebellum in ASD 13–15, a role for the cerebellum in EBL 16–18, and a role for EBL in ASD 19,20. However, the directionality and timing of early developmental relationships among these constructs remains poorly understood. This is a notable gap in the literature, given that ASD is a neurodevelopmental disorder with defining behavioral features that emerge and consolidate across the first 12 and 36 months of life 21. To test the hypothesis that cerebellar connectivity and EBL contribute to the development of ASD, it is necessary to study infants prior to ASD diagnosis. To this end, we propose to analyze previously-collected resting-state functional connectivity (fcMRI) and eye-tracking (EBL) data from the Infant Brain Imaging Study (IBIS), a multisite study of brain and behavioral development in infants at high and low risk for ASD. Specifically, we will evaluate cerebellar connectivity and EBL impairment as longitudinal predictors of ASD diagnosis and severity, as well as dimensionally-measured ASD-associated behaviors. Consistent with prior research 22, we will operationalize EBL as saccadic error (i.e., the frequency, magnitude, and variability of eye movements that fall short of their intended targets). We hypothesize that infant cerebellar connectivity (Aim 1) and EBL impairment (Aim 2) will predict later ASD diagnosis and severity. Further, consistent with “cascade” models of brain-behavior development 23, we hypothesize that infant cerebellar connectivity will influence infant EBL, with implications for ASD outcomes (Aim 3). Findings to support our hypotheses would identify cerebellar functional connectivity and EBL impairment as presymptomatic biomarkers for ASD, facilitating early diagnosis in ASD and helping to pave the way for randomized control trials of presymptomatic interventions. Ultimately, my long-term career goal is to become an independent academic researcher investigating the neural, physiological, and psychological factors that contribute to the development of ASD. This proposal entails trainings in infant neuroimaging and eye-tracking from leading experts in both fields, including sponsor John Pruett and co-sponsor Jed Elison. It will serve as the perfect capstone to my graduate studies, and I intend for it to launch the next stage in my research career.

Public health relevance
Project Narrative The defining behavioral features of autism spectrum disorder (ASD) are not present during the first year of life and, therefore, very early intervention—which is argued to improve outcomes for individuals with ASD—will rely on the identification of reliable presymptomatic biomarkers. Using whole-brain approaches, our group recently identified two neural biomarkers that predict ASD diagnosis with high positive predictive value (PPV > 80%). We will examine the mechanistic bases for these findings by testing whether abnormal infant cerebellar connectivity (a specific neural biomarker) and cerebellar-dependent learning (a related physiological biomarker) predict later ASD outcomes, with implications for the development of targeted presymptomatic interventions.